Sex differences in the developing oxytocin system

There is emerging evidence that during development the neuropeptide oxytocin helps to organize neural circuits in the brain and that these organizational effects may help the brain develop the capacity to execute sex-specific and context-appropriate social behaviors later in life. This R15 proposes to use an animal model to better understand the role of oxytocin during fetal development. The working hypothesis of this grant is that fetal oxytocin is important to the development of the neural substrates that support sex-specific social behaviors in adulthood. To test this hypothesis two specific aims are proposed. The first aim will determine how the developing oxytocin system differs between female and males. The second aim will identify how developmental oxytocin differentially impacts female and male neurochemistry. The proposed research is significant because it would be the first to examine the function of oxytocin signaling during fetal development. Thus, it is expected that these experiments will reveal a novel role for oxytocin in organizing sex-specific brain circuits that are critical for typical displays of social behaviors. This knowledge is relevant to the mission of the NIH and to human health because across mammalian species oxytocin is important for social cognition and social functioning, and deficits in social behaviors are characteristic of several neurodevelopmental neuropsychiatric disorders. Thus, the experiments proposed are important because they will provide insight in the contributions of fetal oxytocin to the proper development of the male and female brain and ultimately to the expression of social behaviors.

Public health relevance
The proposed studies are important because they will provide insight into how oxytocin during fetal life affects the development of the female and male brain and contributes to the development of social behavior. The proposed research has relevance to public health because many of the neural chemicals, neural substrates, and circuits that underlie social behaviors are evolutionarily conserved. Thus, the findings of this work are expected to improve our understanding of the contributions of oxytocin to the development of social behaviors in humans.